Endogenous alpha-to-beta cell transdifferentiation in diabetes

PROJECT SUMMARY AND RELEVANCE An ideal solution to the treatment or cure of diabetes mellitus would be the formation of new functioning β-cells from the patient’s own tissues, thereby avoiding the need for transplant immunosuppression. Abundant recent data has suggested that α-cells are a likely source for endogenous transdifferentiation into β-cells. Here, we describe a pancreatic intraductal viral delivery system in the mouse, where a single infusion of an adeno-associated virus (AAV) carrying a pdx1/mafA expression vector in a diabetic mouse can induce robust and durable α-cell transdifferentiation into β-cells through neogenesis, with recovery of over 60% of the β-cell mass within 4 weeks and persistent, indefinite euglycemia. Serendipitously, when this β-cell neogenesis was induced in NOD mice, the mice became euglycemic for 4 months or more, without any additional therapy or immunosuppression. To our knowledge no clinically applicable β-cell replacement therapy in NOD mice has been successful without immunosuppression. We suspect that the neogenic β-cells may not be rejected because they are “imperfect” β-cells by RNA-seq analysis. Since pancreatic duct injection is routinely performed in humans as a relatively simple, non-surgical procedure, and since numerous viral gene therapy trials are currently ongoing for several diseases, we feel that our approach may be rapidly translatable to humans with diabetes mellitus, potentially both type 1 and type 2. In this proposal we will first better delineate the phenotype of these neogenic mouse β-cells derived from α-cells in terms of function and resistance to stressors that normally can cause β-cell death. We will then strive to better understand how they form, their proliferative capacity, RNA expression and gene methylation profile. We will then study ways to optimize their formation through promoter work for the virus construct, and to better understand ways that anti-AAV neutralizing antibodies may affect the effectiveness of this gene therapy approach. Next, we will pursue the feasibility of a novel lipid nanoparticle technology to replace the need for AAV in the induction of α-to-β-cell transdifferentiation. Since glucagon has been shown to play an important role in α-to-β-cell transdifferentiation, we will study its role in this system. We will study the potential therapeutic effect of such α-to-β-cell transdifferentiation in models of type 2 diabetes mellitus. Lastly, we will investigate the function of human islets that have undergone α-to-β-cell transdifferentiation, both in vitro and in vivo. In summary, we feel that the proposed studies, if successful, should position us well in preparation for clinical trials in humans with diabetes.

Public health relevance
Project Narrative Although great efforts have been made in the field of beta cell replacement therapy, the glaring concern for Type I diabetes is that even if we do develop a way to perform such replacement therapy, those replacement cells would seemingly be doomed to the same autoimmune attack as the original beta cells. Here, we describe a possible solution to this problem. We used a viral intraductal infusion strategy to induce alpha cells in the islets of either alloxan-ablated or NOD (autoimmune) diabetic mice to transdifferentiate into beta cells. This transdifferentiation was robust, leading to recovery of 60% of the beta cell mass in the alloxan-treated mice and a 190-fold increase in beta cell mass in NOD mice. This recovery in the NOD mice lasted 4 months, despite no other interventions, including no immunosuppression. Here, in this proposal, we will analyze the biology of these neogenic beta cells and how they form, both in mice and in human islets, in order to better understand and to optimize the process.